METTL3 in regulation of the aging process

PROJECT SUMMARY
Aging is a complex process where perturbation of multiple molecular pathways contributes to organ
deterioration and aging-related morbidity and mortality. One component of the aging process is severe
dysregulation of gene expression that contributes to changes in the proteome of aged cells, which can
compromise cell function. Understanding the mechanisms responsible for aging-induced perturbation of gene
expression will be key to develop the necessary medical therapies. Although significant progress has been
made in understanding the transcriptional changes occurring with aging, very little is known about how post-
transcriptional events, such as RNA modifications, control protein synthesis during aging. In this proposal we
will examine the role of METTL3-mediated m6A mRNA methylation in the context of aging using muscle aging
as a model system. We hypothesize that METTL3-dependent mRNA methylation regulates the process of
aging by controlling the translation of specific pro-hypertrophic mRNAs. For the first time, utilizing gain- and
loss-of-function approaches we will characterize this novel regulatory program by establishing the molecular
mechanism by which m6A regulates the life of select mRNAs (aim 1), assess the global aging- and METTL3-
dependent m6A profile dynamics and consequent mRNA translation changes (aim 2), and examining the
therapeutic benefit of enhancing m6A content to counteract sarcopenia in clinically relevant animal models (aim
3). Completion of the proposed aims will allow the uncovering of a novel mechanism responsible for post-
transcriptional regulation of aging with significant therapeutics ramifications.

Public health relevance
PROJECT NARRATIVE Aging is a complex process where gene expression programs are perturbed. This proposal will uncover a unified model by which RNA methylation regulates coordinated gene programs with aging. Successful completion of the proposed aims should open exciting new prospective and therapeutic possibilities to favor healthy aging and prolong quality of life.